Nitrosative stress and NO detoxifying reaction mechanisms in microbial nonheme diiron proteins

PROJECT SUMMARY
Metalloenzymes play crucial roles throughout human health and govern the biochemistry of dioxygen (O2) and
nitric oxide (NO). Pathogenic organisms depend on heme and nonheme iron-containing proteins to counter the
human immune response and to survive exposure to high concentrations of reactive oxygen and nitrogen
species (ROS/RNS). The Moënne-Loccoz Lab combines classic biochemical techniques, resonance Raman
(RR), FTIR, and EPR spectroscopies with time-resolved techniques to probe microbial enzymatic systems
characterized by X-ray crystallography, but with catalytic strategies that remain poorly understood or totally
unknown. In this project, a recent crystal structure of a novel mycobacterial diiron protein upregulated upon
macrophage infection is targeted for investigation after showing unique structural features and reactivity toward
RNS never seen before in biology or inorganic chemistry.

Public health relevance
NARRATIVE The goal of this research is to elucidate mechanisms employed by pathogenic microorganisms to combat the mammalian immune response through NO and NOx detoxifying processes. In many cases, redox active metal-containing proteins known to be over-expressed in stress conditions lack assigned physiological functions despite being structurally defined. Kinetic and molecular spectroscopy studies are essential components to the identification and understanding of their catalytic mechanisms.